Development of Human Microphysiological Systems for Testing of AD/ADRD Interventional Strategies across Genetically Diverse Populations

ABSTRACT OVERALL COMPONENT
Alzheimer’s disease manifests along a spectrum of levels of neuropathology, age of onsets and rates of cognitive
decline. Genetic studies support a heterogeneous etiology, with around 70 associated loci, implicating several
biological processes that mediate risk for AD. Studies are just beginning to emerge that attempt to provide
frameworks for subtyping AD based upon biomarker data, genetic data and/or -omics profiles from the
postmortem brain. Despite this, the majority of experimental systems for testing new therapeutics are not
designed to capture the genetically complex drivers of AD. In turn, past clinical trials may have suffered from an
inability to predict individual responsiveness based upon the drivers of disease in AD subtypes. A one-size-fits-
all approach to clinical trials and clinical care is unlikely to be successful across all cases (i.e. anti-amyloid
immunotherapy may work well in a subset of cases but not in others). Successful establishment of the proposed
PRECISION-AD Center, which will establish a toolkit of 2D and 3D microphysiological systems (MPS) that
capture human genetic diversity underlying risk and resilience to AD and report on the function of biological
domains relevant to AD, is an important first step in identifying convergent and divergent mechanisms of AD and
testing person-specific responsiveness to therapeutic interventions. Here, we will leverage a set of iPSC lines
that we recently developed from over 100 participants in the Religious Order Study (ROS) and Memory and
Aging Project (MAP) that span ethnically diverse populations and include deeply phenotyped and genome
sequenced individuals. Our ability to analyze matched brain and plasma from the same individuals provides a
valuable opportunity for cross-platform validation of key molecular findings. Under this award, we have four
overarching goals: 1) To generate an atlas of molecular signatures of 2D and 3D MPS experimental systems
across 100 ethnically diverse genetic backgrounds that are matched with multi-omic data from brain tissue and
plasma from the same individuals; 2) To develop preclinical efficacy assays for testing of six interventional
strategies for AD that target different biological domains and to identify biomarkers of responsiveness to each
intervention; 3) To establish rigorous, automated pipelines for scaling preclinical assays of efficacy to enable
testing of interventional strategies across diverse genetic backgrounds, and 4) To establish robust pipelines for
open-access sharing and distribution of MPS models, methods, and data to ensure facile distribution to scientists
from the academic and biopharma communities. To accomplish these goals, we have assembled a
multidisciplinary team with deep experience in Alzheimer’s biology, stem cell modeling, drug discovery,
screening, lipidomics, proteomics, computational biology, and open resource sharing platforms. Together, we
aim to develop 2D and 3D models as scalable platforms for the use as precision medicine research tools to
investigate the complex biology of AD and to accelerate drug discovery and preclinical drug development.

Public health relevance
NARRATIVE OVERALL COMPONENT Clinicians and neuropathologists have long recognized that patients with Alzheimer’s disease have a wide spectrum of ages of onset, rates of cognitive decline, and amounts of plaque and tangle burden in their brain. More recently, genetic studies also support the concept that there are different molecular roads leading to AD. Here we aim to establish a set of all-human cellular systems that capture the diversity and subtypes of AD and allow scientists around world to test candidate therapeutics in a person-specific manner.